Quantitative magnetic resonance imaging and automated textural radiomics for assessment of human placenta accreta spectrum

PROJECT SUMMARY
Placenta Accreta Spectrum (PAS) disorder is a condition in which the placenta fails to separate partially
or totally from the uterine wall, resulting in significant intrapartum maternal morbidity and mortality at delivery.
Depending on the extent of the placental invasion into surrounding tissue, hysterectomy may be lifesaving.
Assessment of PAS severity prior to delivery is crucial for multidisciplinary surgical planning and patient
counseling. However, there is an unmet clinical need for quantitative, objective measures of abnormal
placentation that can serve as predictors of risk of invasion and hysterectomy. The overall goal of the proposed
project is to prospectively assess PAS in high-risk women across gestation using quantitative multi-parametric
magnetic resonance (MR) imaging and automated textural radiomics and to correlate findings with surgical
outcomes.
Coming from a highly interdisciplinary background of MR chemistry, biology, and physics, the
candidate's long-term career goal is to become an independent investigator with in-depth knowledge and skills
to conduct translational placental imaging research. The candidate's short-term goal is to complete a pilot
study under the mentorship of an interdisciplinary advisory committee to evaluate PAS in women with high-risk
pregnancies using multi-parametric MRI and textural radiomics.
To meet these goals, the following research aims are proposed: 1) Evaluate placental invasion across
gestation using multi-parametric MR imaging and deep learning based novel quantification tools in PAS high-
risk pregnancies, and 2) Extract the radiomic pattern across gestation of high-risk PAS placenta and determine
its association with clinical surgical outcome. These research aims will serve as the platform for the career
development plan and training aims which include: 1) Gain knowledge in translational prospective research
design, 2) Improve technical skills in advanced clinical MR acquisition development, 3) Acquire applied
statistical and data analysis skills, and 4) Develop mentorship and leadership skills while under training.
Together, the research and training aims will provide the training, experience and preliminary data for
an R01 application. The future R01 will develop a clinical and surgical outcome prediction model for high-risk
PAS pregnancies, potentially improving maternal and fetal outcomes. The training will position the candidate to
become a leader in translational placental imaging research.

Public health relevance
PROJECT NARRATIVE After a woman has had a cesarean delivery, if the placenta implants on the surgical scar in a subsequent pregnancy, there is a risk for invasion, referred to as placenta accreta spectrum (PAS); depending on its severity, a cesarean hysterectomy may be required with significant morbidity. Imaging techniques such as magnetic resonance (MR) imaging have shown promise in defining characteristics that alert the obstetrician to the severity of PAS. We will explore the vascularity and tissue characteristics of the placenta with MRI and identify quantitative predictive markers of disease severity and hope to better understand the pathophysiology of placenta accreta spectrum.